PHASE I TRIAL INTERLEUKIN 1 ALPHA AND CYCLOPHOSPHAMIDE IN SOLID TUMORS

The purpose of this study is to asses the biologic effects of Interleukin-1 alpha and, in particular, its effectiveness as a marrow protective agent in patients receiving cyclophosphamide chemotherapy.